Innate immune regulation of neuroinflammation

PROJECT ABSTRACT
Inflammation in the central nervous system (CNS) is causally associated with the pathogenesis and
progression of multiple demyelinating and neurodegenerative diseases, including Multiple Sclerosis (MS),
Parkinson's Disease, Alzheimer's Disease, Amyotrophic Lateral Sclerosis, and general age-associated
cognitive decline Therefore, there is an urgent need to develop novel approaches to prevent, limit or reverse
neuroinflammation. Basic, translation and clinical studies indicate that T cells can be major drivers of
inflammation in the CNS, but the mechanisms promoting or inhibiting these responses remain poorly defined.
The fundamental focus of this research proposal is to: (i) interrogate a novel pathway by which the
innate immune system controls T cell responses in the CNS, (ii) understand the regulation of these
cellular interactions, and (iii) define whether it is possible to harness this or related pathways for
therapeutic benefit in neuroinflammation. We will employ innovative approaches and develop new tools to
address these fundamental gaps in knowledge, and where possible, translate our findings from mice into
clinically defined patient samples. Results from these studies will advance our understanding of the
pathways that promote or inhibit pro-inflammatory T cell responses in the CNS, and could provoke the
next generation of novel preventative, therapeutic or curative treatment strategies for demyelinating
and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Pro-inflammatory T cell responses in the central nervous system are causally associated with multiple demyelinating and neurodegenerative diseases, including Multiple Sclerosis, Parkinson's Disease, Alzheimer's Disease and age-associated cognitive decline, which collectively affect over 7 million Americans and requires annual health care costs approaching one trillion dollars. The focus of this proposal is to define the role and regulation of a novel pathway that critically controls T cells in neuroinflammation, and determine its therapeutic potential to limit disease.